Airway Progenitor Cell Profileration and Differentiation During Lung Repair

DESCRIPTION (provided by applicant): Airway Progenitor Cell Proliferation and Differentiation during Lung Repair This application responds to RFA-HL-12-006 to participate in a Consortium for the study of Lung Repair and Regeneration. The proposal seeks to establish a participating Center working closely with other national Consortium members. Our proposed Center consists of faculty led by Dr. Jeffrey Whitsett at Cincinnati Children's Hospital IVIedical Center (CCHMC) and Dr. Philip Streeter at the Oregon Health and Science University (OHSU), who have established collaborations for the study of lung biology. Our Center provides four specific aims, all focused to transcriptional mechanisms controlling proliferation and differentiation of Airway Epithelial Cell (AEC) progenitors. The Aims also generate and provide new antibodies, gene expression data and transgenic models of broad application to the field of Pulmonary Biology and Medicine. Aim 1 will elucidate the role of a novel transcriptional network controlling AEC progenitors and their differentiation in conducting airways, with focus to the role of a PAX9-centered transcriptional network in the regulation of basal cell proliferation and differentiation. Aim 2 will produce, characterize and use monoclonal and polyclonal antibodies for the identification and purification of human and mouse AECs for study of lung repair and disease. Aim 3 will define gene expression patterns and transcriptional regulators critical for AEC homeostasis with focus to PAX9 and associated factors. This Aim will create and standardize expression and transcriptional databases for human and mouse AECs and iPS cells induced to specific airway cell lineages. Aim 4 will produce novel transgenic mice for the conditional deletion and addition of genes in conducting AECs, including those related to the study of PAX9. Preliminary data accompanying this application were produced via close collaborations and interactions between members of laboratories in multiple divisions at CCHMC in the fields of Pulmonary Biology, Developmental Biology, Hematology/Oncology, and Bioinformatics, as well as those at OHSU and the Oregon Stem Cell Center. Our investigators have long-standing commitments and success related to the building and sharing of useful technologies and reagents and have been long committed to training others to advance the field of pulmonary biology and medicine. RELEVANCE (See instructions): This U01 grant seeks to provide (1) novel insights into the molecular and cellular control of AEC progenitors and their differentiation and (2) novel reagents, tools and procedures enabling scientific advancements of value to the field of pulmonary medicine.